The next generation of liquid biopsies: Predictive and pharmacologic biomarkers

Project Summary:
The laboratory of Dr. Joshua Lang is focused on targeting treatment resistant PCa through developing new
biomarkers for precision medical strategies using liquid biopsies; discovering novel vulnerabilities in PCa; and
translating these discoveries and biomarkers into clinical trials. Dr. Jamie Sperger has been an integral part of
Dr. Lang’s laboratory for the past 11 years and has contributed to 3 NCI funded RO1 projects and co-authored
24 publications. Together, Drs. Lang and Sperger have developed novel liquid biopsy assays which helped
identify persistent Androgen Receptor (AR) signaling in men treated with AR signaling inhibitors (ARSIs) due to
complex genomic alterations, including AR gene rearrangements, amplifications, and mutations that can be
detected in liquid biopsies. Currently Dr. Sperger leads two NCI funded projects in the Lang laboratory. The first
project “Molecular regulation of Trop-2 in advanced prostate cancer: Biomarkers and therapeutic niches”
(R01CA276269) aims to leverage liquid biopsies as a tool to better understand which patients might benefit from
Trop-2 targeted therapies. The second project titled “Enhancing epigenetic analysis of rare cells with multi-phase
microfluidics” aims to develop novel methods to detect epigenetic changes by developing new methods using
technology co-developed with the laboratory of Dr. David Beebe. Dr. Sperger is uniquely qualified to lead these
projects, with over a decade of experience with assay development for liquid biopsies using microfluidics.

Public health relevance
Project Narrative: There is a critical need to better understand the development of resistance to targeted therapies and to identify new targets for treatment of metastatic prostate cancer. As an integral member of the laboratory of Dr. Joshua Lang, Dr. Jamie Sperger has developed novel liquid biopsy assays aimed at tackling these questions and they are now using these tools to monitor the emergence of resistance in prostate cancer to improve our understanding of cancer, develop new therapeutic interventions and supporting biomarker development.